Short Course for Action-Oriented Research on Firearm Injury Prevention

PROGRAM ABSTRACT
Firearm injury poses a multifaceted threat to the nation’s public health and there is extensive evidence showing
that firearm injuries are associated with extensive racial, ethnic, gendered, socioeconomic, life course, and
geographic health inequities, This program, the Short Course for Equity-Centered Action-Oriented Research
on Firearm Injury Prevention (SEAR), will develop, implement, and evaluate a 12-week short course, designed
to equip nurse scientists and scientists in aligned fields to lead research and develop interventions across a
range of firearm injury prevention priorities. The overarching premise of SEAR is that firearm injury research is
health equity research and that firearm injuries are both a consequence of social determinants of health and a
critical upstream determinant of health and wellbeing. As such, the course focuses on four core training
themes: 1) social and structural determinants of firearm injury, 2) healthcare in the aftermath of firearm injury,
3) recovery and reinjury prevention, and 4) community-partnered and policy approaches to address firearm
injury inequities. Through in-person and virtual learning, mentorship, and network building, 60 developing
nurse scientists and scientists in aligned fields, across three cohorts and three program years, will gain new
expertise and support through which they will begin their pathway to impactful scientific contributions for the
prevention of firearm injuries and associated harms.
Situated in the scientific environment of the University of Pennsylvania's School of Nursing and Penn’s CDC-
funded Injury Control and Research Center, in collaboration with Vanderbilt University, SEAR leverages the
vast resources of both institutions, including research centers, training programs, faculty, and community-
based partners. The program is designed by a Core Faculty of leading firearm injury and injury nurse scientists
and supported by an exceptional interdisciplinary Affiliated Faculty with diverse disciplinary and institutional
affiliations. SEAR has the following specific aims: Aim 1 is to deliver focused research training for nurse
scientists and scientists in aligned fields to conduct equity-centered actionable research on the prevention of
firearm injury and firearm injury harms; Aim 2 is to create a robust, diverse, cadre of nurse scientists and
scientists in aligned fields with an extended peer and mentor network to advance research on the prevention of
firearm injury and firearm injury harms; Aim 3 is to evaluate and improve the feasibility, acceptability, and
effectiveness of research training to maximize nursing and aligned fields’ contribution to prevention of firearm
injury and firearm injury harms. When achieved, SEAR will meet the purpose of PAR-24-061 and align
seamlessly with National Institute of Nursing Research's strategic priority to build knowledge, capacity, and
equitable educational access for nurse scientists and scientists in aligned fields to lead research, addressing
the pressing health challenge of firearm injury prevention, and advance health equity into the future.

Public health relevance
The Short Course for Action-Oriented Research on Firearm Injury Prevention (SAR) aims to equip developing nurse scientists and scientists in aligned fields with the knowledge, skills, mentoring, and connections necessary to advance research on firearm injury prevention and the prevention of its broad associated harms with a focus on determinants of health. This 12-week training program designed for pre- and post-doctoral and early career nurse scientists and scientists in aligned fields who are novices in firearm injury research, combines in-person and virtual learning at the University of Pennsylvania School of Nursing and in collaboration with the Penn Injury Science Center and Vanderbilt University. The intended outcome of SAR is a new cadre of scholars prepared to fill critical gaps in scientific knowledge on the determinants of firearm injury, innovative healthcare solutions, effective recovery strategies, and impactful approaches to firearm injury prevention, in alignment with NINR’s mission and research lenses.